Identifying circuit-level neuromarkers of smoking dependence that change in response to intervention

Abstract
Although half of the 37 million adult smokers in the US attempt to quit each year, only an estimated 3% are
successful. Smoking is associated with changes in brain circuitry that drive incentive salience valuation and
executive control. Over time, the incentive salience of smoking cues become enhanced, while the salience of
non-smoking rewards are diminished. Further, executive control over smoking motivation and drives becomes
impaired. While functional magnetic resonance imaging (fMRI) has identified brain circuitry associated with
incentive salience valuation and executive control, we currently have a limited understanding of how this brain
circuitry changes with cessation treatment and reductions in dependence. Characterizing changes in
neurocircuitry during smoking cessation has the potential to inform the development of targeted
neuropharmacological, behavioral, and brain stimulation cessation interventions. This proposal aims to provide
the candidate with training and research to address this critical gap in our identification of modifiable
neuromarkers of smoking dependence. The candidate will conduct a double-blind, 6-week, randomized trial of
very low nicotine content cigarettes among smokers while collecting longitudinal fMRI measures over 3 time-
points. The MRI tasks will engage incentive salience valuation of smoking and non-smoking rewards and
executive control through inhibition and decision making. These tasks will include a respiration-triggered-event-
related sequence to measure smoking odor cue reactivity, an understudied, but potentially potent secondary
smoking reinforcer. With a mentorship team of experts in tobacco use, human olfaction, fMRI, and longitudinal
analysis and the support of the Penn State Tobacco Center of Regulatory Science, the candidate will emerge
as a patient-oriented clinical researcher contributing to our neurobehavioral understanding of smoking
dependence and tobacco use.

Public health relevance
Project Narrative (Public Health Relevance) Despite widespread public interest and motivation to quit smoking, current cessation interventions are ineffective for the vast majority of those who try. The proposed study aims to further our understanding of smoking dependence by identifying modifiable neurobiological markers that can serve as potential targets of neuropharmacological cessation interventions and measures of treatment success.